mTOR Regulation of Basal Antiviral Immunity in the Elderly

Abstract
Given the elevated mortality of COVID-19 infections in older adults (Wu et al 2020), there is an
urgent need to evaluate medicines that may prevent severe disease in these vulnerable
patients. Inhibition of targets downstream of target of rapamycin complex 1 (TORC1) was
reported to upregulate pan-antiviral gene expression and protect mice from a viral respiratory
tract infection (RTI) (York AG et al. 2015). Importantly, RTB101 was also observed to
upregulate interferon-stimulated pan-antiviral gene expression, decrease the levels of
inflammatory cytokines in serum, and decrease the incidence and severity of viral respiratory
tract infections including coronavirus infections when given as prophylaxis during winter cold
and flu season to older adults (Mannick et al. 2018, Mannick et al., 2019). Therefore we
hypothesize that RTB101 will decrease the incidence and severity of COVID-19 when given as
prophylaxis to older adults. Before undertaking a large well-powered trial for this indication, we
propose to undertake a pilot study to determine the feasibility of recruiting, consenting,
screening and randomizing quarantined outpatient populations of older adults who are predicted
to be at increased risk of developing COVID-19 (Specific Aim 1), assess whether COVID-19
symptoms can be tracked using an eDiary in older adults (Specific Aim 2), and obtain
preliminary data on the incidence and severity of COVID-19 in subjects treated with RTB101 as
compared to placebo (Specific Aim 3). The data generated in the trial will be used to help
optimize the study design of a larger adequately powered study to determine if RTB101 is
effective as COVID-19 prophylaxis in the older adults.

Public health relevance
Project Narrative Medical interventions that improve the function of the aging immune system may help prevent or decrease the severity of COVID-19 in older adults. In clinical studies of people age ≥ 65 years, an oral drug called RTB101 was observed to increase the expression of antiviral genes in blood cells and decrease the incidence and severity of respiratory tract infections caused by multiple viruses including coronaviruses. In this grant application, we propose to do a pilot clinical trial to gain insight into the feasibility and optimal design for a subsequent larger clinical trial of RTB101 to decrease the incidence or severity of COVID-19 in older adults.